Time-keeping mechanisms of embryonic cell cycles

ABSTRACT
During embryonic development each body part is programmed to contain an accurate number and arrangement
of cells. This accuracy is achieved through precise regulation of cell proliferation. The overarching goal of this
proposal is to reveal the mechanisms that ensure accurate control of the cell cycle during Drosophila embryonic
development. We will study three fundamental questions of cell cycle regulation in morphogenesis by addressing
the following Aims. In Aim 1, we will study how the interplay of biochemical and mechanical signals ensures
accurate nuclear positioning. Specifically, we will address how the activity of the cell cycle oscillator and
microtubule cytoskeleton are integrated to control nuclear migration to the embryo cortex. In Aim 2, we will study
how the nuclear-to-cytoplasmic ratio controls the cell cycle via the activation of the DNA replication checkpoint
and zygotic genome activation. We will also investigate the feedback mechanisms by which the cell cycle and
zygotic expression influence each other and ensure a robust maternal-to-zygotic transition. In Aim 3, we will
elucidate how transcriptional regulation of cdc25string ensures precise regulation of the timing of mitosis during
gastrulation. We will also investigate the mechanisms controlling mitotic domains on the dorsal side of the
embryos, where they are directly linked to the dynamic of the Decapentaplegic (Dpp) morphogen gradients.
Collectively, our experiments will define a quantitative framework elucidating how the cell cycle is regulated
accurately during embryonic development.

Public health relevance
PROJECT NARRATIVE Our project addresses the fundamental question of how the cell division cycle is timed precisely during embryonic development. Such precision is required for normal development and function of multicellular tissues. Perturbations of the timing of the cell cycle can lead to embryonic lethality and diseases, including cancer.